WASHINGTON UNIVERSITY INTELLECTUAL AND DEVELOPMENTAL DISABILITIES RESEARCH CENTER

ABSTRACT
This IDDRC administrative supplemental application builds on a successful collaboration of the Intellectual and
Developmental Disabilities Research Centers (IDDRCs), in which investigators at 12 centers implemented the
NIH-funded Brain Gene Registry (BGR) to understand the impact of rare variants in intellectual and
developmental disabilities (IDD) genes. As a multisite network-wide collaborative project, the BGR promotes
translational research spanning the nearly 3,000 purported IDD genes by uniquely linking genotypic and
phenotypic data, remotely capturing rapid neurobehavioral assessment (RNAP) data, and collecting correlative
electronic health record (EHR) data. To accelerate the translational advances arising from this unique cross-
IDDRC resource, we propose to use this IDDRC administrative supplement to sustain the growth of the BGR
both in terms of participant accrual and data usage. In Aim 1, we will collect participant data through
collaborations with GenomeConnect, individual sites for EHR data, and centralized administration of the remote
behavioral assessment protocol (RNAP) using our CIELO platform BGR database. To encourage recruitment
and reduce participant burden, we will assess strengths and redundancies in multimodal data collection. We will
validate the remote neurobehavioral assessment protocol (RNAP) with traditional in-person assessment and
explore the use of Artificial Intelligence (AI)-based methods to extract meaningful information from the EHR to
reduce the high burden on participants and improve data completeness. In Aim 2 we will resolve IDD gene and
variant pathogenicity through partnerships with ClinGen by leveraging the paired genotypic and phenotypic BGR
data to curate and reclassify variants under the ClinGen Gene and Variant Curation Expert Panel framework. In
Aim 3, we will develop strategies to facilitate use of BGR by investigators and patient advocacy groups (PAGs)
by simplifying data access and disseminating information to participants and researchers. These initiatives build
capacity and access to a shared IDD resource by investigators within and beyond the IDDRC network, as well
as patient advocacy groups.

Public health relevance
NARRATIVE This is a supplemental funding request for activities of the Intellectual and Developmental Disabilities Research Center (IDDRC) Brain Gene Registry (BGR) that falls entirely within the scope of the current P50 grant to Washington University (IDDRC) (P50HD103525). To accelerate the translational advances arising from the BGR, we propose to sustain patient accrual and use of the data contained in this powerful IDDRC Network resource. These initiatives build capacity and access to a shared IDD resource by investigators within and beyond the IDDRC network, as well as patient advocacy groups.